Genetic Mapping of m6A and Pseudouridine RNA Modifications in the Aging Human Brain and Their Impact on Alzheimer's Disease

PROJECT SUMMARY
In this project, we propose to investigate the role of RNA modifications in Alzheimer's disease (AD) through an
innovative integration of genetics, multi-omics analysis, and functional validation. Recognizing that the molecular
mechanisms underlying AD onset and progression remain incompletely understood, our study aims to examine
how genetic variants influence N6-methyladenosine (m6A) and pseudouridine (Ψ) modifications in aging brains
and their contributions to AD pathogenesis. Our overarching goal is to map RNA modifications in human brain
cells, identify their genetic regulators, and understand their causal roles in AD through three integrated aims: (1)
Creating a comprehensive atlas of m6A and Ψ modifications in human brain cells from multiple ancestries and
mapping their quantitative trait loci (RNAmQTL); (2) Integrating RNAmQTL with other molecular QTL and AD
genome-wide association study (GWAS) data to elucidate the molecular functions of RNA modifications and
their impact on AD; and (3) Characterizing molecular and cellular phenotypes of candidate m6A sites and AD
risk genes using human iPSC models. The impact of this work extends beyond providing the first genetic study
of RNA modifications in human brain. By leveraging genetic variation as natural perturbations, we can distinguish
causal factors in AD pathogenesis from reactive changes that merely respond to disease progression. Our
approach combines novel experimental technologies (CAM-seq, BID-seq) with advanced statistical methods for
multi-context QTL integration (ColocBoost, multi-cTWAS) to reveal new mechanisms underlying AD. This project
promises to identify novel therapeutic targets with clear genetic underpinnings, potentially leading to the
discovery of new AD biomarkers and treatment strategies.

Public health relevance
PROJECT NARRATIVE We aim to understand the molecular mechanisms underlying Alzheimer's disease (AD) by studying how genetic variants modulate RNA modifications in specific brain cell types. Using novel sequencing and computational technologies to map these modifications in aging human brains from diverse ancestries, and leveraging genetic variation as natural experiments, we can identify genes and processes with causal roles in AD, rather than those merely responding to disease progression, and validate these findings using human stem cell models to understand their effects on brain cell function. Our results will potentially lead to discoveries of new AD biomarkers and targets for novel therapeutic strategies.